Effects of Re-expression of Motor Neuron Selector Transcription Factors on ALS Pathology

The fact that young neurons are impervious to mutations that cause late-onset neurodegenerative
diseases highlights the critical role of aging in disease etiology. Recently we established that spinal motor
neurons undergo a complex maturation program in postnatal mice during which genes encoding the proteasome
and chaperonin complex are downregulated, suggesting that motor neurons become less adept at managing
and degrading misfolded proteins over time. We hypothesize that these gene expression changes underlie the
increased vulnerability of adult motor neurons to mutations causing amyotrophic lateral sclerosis (ALS). To test
this hypothesis, we will re-express the embryonic motor neuron selector transcription factors ISL1 and LHX3 in
postnatal motor neurons in mouse models of ALS in vivo and in iPSC-derived ALS motor neurons in culture. We
will examine the effects of ISL1 and LHX3 re-expression on early and late pathologies observed in ALS mouse
models and on motor neuron survival in response to proteostatic stress in vitro. We will also evaluate changes
in gene expression, chromatin binding and accessibility, and DNA methylation. Jointly these studies will provide
new insights into the effects of heterochronic expression of embryonic selector transcription factors on mature
neurons, and explore their therapeutic potential.

Public health relevance
We will examine whether re-expression of ISL1 and LHX3, the transcription factors that control immature motor neuron identity, can re-activate early gene expression programs in adult motor neurons and make them more resistant to mutations that cause the late-onset neurodegenerative disease amyotrophic lateral sclerosis.